Identifying Clinic Barriers and Facilitators Affecting the Implementation of a Mobile App-Based Treatment for Disorders of Gut-Brain Interaction in Children.

PROJECT SUMMARY/ABSTARCT
Disorders of gut-brain interaction (DGBI; formerly known as functional abdominal pain disorders) like irritable
bowel syndrome are highly prevalent worldwide in children and adults. They are associated with significant
morbidity and incur substantial healthcare costs. The etiology of DGBI is multifactorial as described by the
biopsychosocial model. Psychological distress, including anxiety and depression, is highly associated with DGBI,
and cognitive behavioral therapy and its variant guided imagery therapy (GIT) are efficacious first-line treatments
per experts and clinical guidelines. Unfortunately, individual and systemic barriers often impede regular in-person
therapy visits. Alternatively, researchers have demonstrated that remotely delivered CBT and GIT via compact
discs and websites are efficacious, which led to the development of a K23-supported, patient-centered guided
imagery therapy mobile application (GIT App). However, our current K23 research nor the medical literature
inform best practices for implementing such a therapeutic App in pediatric clinics. Further, our preliminary data
shows that our clinicians infrequently refer children with DGBI to any psychological therapy. This proposal aims
to identify our clinic personnel’s perceived implementation determinants (i.e., barriers and facilitators) for rolling
out the GIT App within our pediatric clinics. To address this known barrier and discover unforeseen barriers and
inherent facilitators possibly affecting the implementation process, this proposal will solicit our clinic personnel’s
perspectives of these factors to inform a future GIT App implementation strategy that can guide clinic personnel
activities necessary to promote the implementation of the GIT App in this setting. Guided by the theory of
Organizational Readiness for Change and the Consolidated Framework for Implementation Research, we will
use qualitative and quantitative research methods to (1) assess our clinicians' perspectives about the infrequent
referral of patients with DGBI to psychological therapy and (2) identify perceived barriers and facilitators to the
implementation of the GIT App intervention in our pediatric clinics. Aim 1 will involve qualitative interviews with
clinicians to better understand their views on barriers to referral. For Aim 2, we will use mixed-methods research
by first quantitatively assessing clinic personnel’s organizational readiness for implementing the GIT App
intervention within our pediatrics clinics by using the validated Organizational Readiness to Change Assessment
(ORCA) instrument. Then we will conduct qualitative interviews with the same clinic personnel who have highest
and lowest ORCA readiness scores and capture their respective perspectives about perceived barriers and
facilitators affecting GIT App intervention implementation. The combined results of Aims 1 and 2 will inform a
GIT App implementation strategy for our pediatric clinics that can be evaluated in a future hybrid effectiveness-
implementation trial. Results from the current study is likely to be applicable to implementing other therapeutic
mobile apps within clinics and also help initiate a sea change in the care delivery of children with DGBI.

Public health relevance
PROJECT NARRATIVE Disorders of gut-brain interaction (DGBI, former known as functional abdominal pain disorders) like irritable bowel syndrome are highly prevalent worldwide in children and adults and are associated with significant morbidity like increased psychological distress (e.g., anxiety and depression) and impaired health-related quality of life. Based on clinical trials demonstrating consistent efficacy of psychological therapies especially when delivered remotely, we developed a patient-centered guided imagery therapy mobile application (GIT App) to treat children with DGBI; however, insight about how to implement such a therapeutic mobile app within pediatric clinics is unclear. Utilizing implementation science methodologies, this proposal aims to identify local clinic personnel’s perspectives about their perceived barriers and inherent facilitators that may impact the implementation of our GIT App intervention in pediatric clinics to ultimately increase access to an optimal psychological therapy and improve health outcomes for pediatric patients with DGBI.